Mechanisms of mitochondrial genome integrity in familial and idiopathic Parkinson's disease

ABSTRACT
Parkinson’s disease (PD) is the most common neurodegenerative movement disorder and over ten million
people worldwide are living with PD. To date, treatments are only symptomatic; they do not alter the inexorable
progression of the disease. The most common cause of familial and idiopathic PD are mutations in leucine-rich
repeat kinase 2 (LRRK2). LRRK2-associated and idiopathic PD demonstrate mitochondrial impairment, however
our understanding of the molecular underpinnings of mitochondrial dysfunction in PD is limited. In our efforts to
understand the underlying mechanisms driving mitochondrial dysfunction, we found that mitochondrial DNA
damage is a shared phenotype amongst both LRRK2-associated and idiopathic PD. Unrepaired mitochondrial
DNA damage can have major adverse cellular effects, impacting genetic and protein instability, compromising
bioenergetic function, increasing reactive oxygen species, and triggering cell death. Recent preliminary studies
by the Sanders lab has found that blocking kinase activity of ATM (a kinase that functions to sense, signal and
promote repair of DNA damage) rescues PD-induced mitochondrial DNA damage. We further observed that
ATM is activated and initiates the DNA damage response pathway. Interestingly, mitochondrial DNA repair
capacity is impaired with a concomitant increase in specific mitochondrial oxidative DNA lesions. Our central
hypothesis is that dysfunctional LRRK2 triggers the ATM-mediated DNA damage response pathway, which
impairs mitochondrial DNA repair capacity, leading to an increase in mitochondrial DNA damage, ultimately
promoting downstream pathogenic PD cascades. We will test this hypothesis with three specific aims that
integrate molecular, biochemical and cellular techniques using established neuronal and murine PD models. Aim
1 will determine the molecular nature of the mitochondrial DNA damage and the dependency on LRRK2 kinase
activity. Aim 2 will define the cellular mechanism(s) by which mitochondrial DNA damage accumulates in PD.
Aim 3 will determine the contribution of ATM to PD-associated phenotypes. This project will advance our
understanding of LRRK2 function in maintaining mitochondrial homeostasis. Further, preclinical testing may
establish ATM as a viable therapeutic target and lay the foundation for the development of neuroprotective PD
therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The most common cause of idiopathic and familial Parkinson’s disease, an adult onset movement neurodegenerative disorder, are mutations in leucine-rich repeat kinase 2 (LRRK2). The overarching goal of this proposal is to understand the underlying mechanisms of mitochondrial DNA damage, a shared phenotype between LRRK2-associated and idiopathic PD. It is hoped that cellular pathways involved in maintaining mitochondrial genome integrity will reveal potential new therapeutic strategies to treat this devastating disease.